Advancing Identification of Circadian Delay in ADHD Youth: Associations with Clinical Heterogeneity and Cognition

Attention-deficit/hyperactivity disorder (ADHD) is associated with substantial societal burden and personal
impairment across the lifespan. Although empirically-based treatments exist, ADHD is highly heterogeneous
with respect to treatment response as well as ADHD-related clinical profiles, including psychiatric comorbidity,
cognitive performance, and sluggish cognitive tempo (SCT). Personalized treatments attuned to the biology
and behavior of the child are critically needed to reduce the burden of ADHD. Sleep disturbances, particularly
difficulties falling asleep and delayed/irregular sleep schedules, are implicated in ADHD and may represent key
candidates for elucidating clinical heterogeneity and personalizing ADHD treatment. Two distinct mechanistic
pathways (i.e., behavioral and biological) may contribute to sleep disturbance in ADHD. Both are characterized
by difficulties falling asleep and delayed/irregular sleep schedules but are mechanistically distinct. In the
behavioral pathway, sleep disturbances stem from ADHD symptoms (e.g., disorganization) and psychiatric
comorbidity (e.g., oppositionality), while the biological pathway is characterized by an endogenous circadian
rhythm delay. Although the behavioral pathway has received significant scientific attention to date, very little is
known about the prevalence, impact, and optimal treatment of the biological (circadian) pathway in middle
childhood—the peak period of ADHD diagnosis. Importantly, the development of identification and treatment
strategies for children with circadian dysfunction has been limited by gold-standard circadian assessment (dim
light melatonin onset [DLMO]), which is burdensome for families and difficult to implement in routine clinical
settings. The overarching objective of this study is to characterize circadian function among 250 children with
ADHD (ages 6-9) using gold-standard DLMO assessment and to establish the implications of circadian
dysfunction for clinical and cognitive functioning. In addition, this study employs innovative wearable sensors
(e.g., heat flux, rest/activity, mattress-based) to determine whether low-burden, in-home assessments have
utility in identifying circadian dysfunction among children with ADHD. Aim 1 will characterize individual
differences in circadian function, including behavioral and biological sleep profiles, in pediatric ADHD using lab-
based DLMO, actigraphy, and parent report. Aim 2 will examine associations between circadian dysfunction,
ADHD clinical presentation, and cognition. Aim 3 will investigate the utility of wearable sensors for indexing
circadian dysfunction in children with ADHD. If successful, this study may transform clinical practice by
facilitating holistic, objective sleep assessments in pediatric settings, which may spur the development of
personalized treatments (e.g., behavioral sleep management therapy for behavioral pathway, chronotherapy
for the biological pathway). Although we focus on ADHD, our methods have transdiagnostic applications. From
a public health perspective, the improved measurement and treatment of sleep problems has the potential to
improve educational, interpersonal, and occupational outcomes and result in broad economic savings.

Public health relevance
Project Narrative Sleep disturbances, particularly difficulties falling asleep and delayed/irregular sleep schedules, are common in Attention-Deficit/Hyperactivity Disorder (ADHD) and are key contributors to clinical and cognitive impairments, thus compounding the burden of the disorder on children, families, and society. However, underlying causes of sleep disturbances in ADHD are likely variable, and the biological pathway (which is characterized by delayed circadian rhythms) has yet to receive adequate scientific attention during middle childhood, in part due to challenges assessing circadian functioning in children’s natural (home) environment. The current study combines gold-standard lab-based and innovative home-based assessments of circadian function in children with ADHD during the peak period of diagnosis (ages 6-9) to advance methods for identifying circadian delay in this population, characterize the specific role of circadian dysfunction in clinical and cognitive functioning in ADHD, and inform the development of personalized sleep treatments that enhance the overall health and functioning of youth with ADHD.